Post-Transplant Inflammatory Response

Abstract
Acute allograft rejection is a T cell mediated immune response that continues to undermine the success of
transplantation to treat end-stage organ disease. Two key factors contributing to acute and chronic allograft
injury and graft loss are ischemia-reperfusion injury (IRI) and heterologous immunity by heterologous memory
T cells with reactivity to graft alloantigens, but whether these factors are connected and how has not been
tested. Reperfusion of ischemic tissues is an inherent component of transplantation and quickly induces an
acute inflammatory response that directs the infiltration and activation of many types of leukocytes into the
tissue. Clinically, the presence of donor-reactive memory T cells in the peripheral blood of kidney transplant
patients prior to transplant is associated with increases in acute rejection and delayed graft function resulting in
poorer graft survival. Studies performed during the last funding period indicated that heterologous memory
CD8 T cells rapidly infiltrate cardiac allografts and are activated by graft allogeneic class I MHC molecules to
proliferate and produce IFN-γ and other inflammatory factors mediating graft tissue injury. The infiltration and
activities of these memory CD8 T cells are markedly increased in allografts subjected to longer duration of cold
ischemic storage (CIS) prior to transplant and require helper signals generated by donor-reactive CD4 T cells
that infiltrate the allograft. The resulting increases in the IRI and activation of these memory CD4 and CD8 T
cells promotes costimulatory blockade resistant memory CD8 T cell mediated rejection of the allografts. These
and our preliminary results have led us to propose the hypothesis that reperfusion of allografts subjected
to prolonged CIS initiates a TLR9-dependent cycle of graft inflammation promoting pre-existing donor-
reactive memory CD4 T cells to generate helper signals required for heterologous memory CD8 T cell
activation to proliferate and express functions mediating acute graft injury and rejection. The
hypothesis will be tested in two specific aims: first, we will test the role of TLR9 signaling in activating innate
immune components that promote donor-reactive memory CD4 cells to generate help required for
heterologous CD8 T cell responses to mediate graft rejection; and, second, we will test the source and role of
IL-21 in heterologous memory CD8 T cell activation to express functions mediating acute graft injury. The
proposed experiments in this renewal application will connect IRI with pre-existing donor-reactive memory CD4
and CD8 T cell activation in allografts and provide novel insights into mechanisms underlying an important and
poorly understood clinical problem. We anticipate these studies will identify new targets for development of
therapeutic strategies to inhibit innate immune enhancement of pre-existing/heterologous donor-reactive
memory T cells in grafts and the acute graft injury mediated by these activated memory T cells.

Public health relevance
Project Narrative Acute allograft rejection is a T cell mediated immune response that continues to undermine treatment of end- stage organ disease through transplantation. The infiltration of endogenous memory T cells into allografts occurs early after reperfusion and the experiments proposed in this study will test the mechanisms of memory CD8 T cell activation to directly mediate increased graft tissue injury and rejection of cardiac allografts subjected to prolonged cold ischemic storage. The results should unveil new therapeutic targets for development of strategies to decrease this inflammation and inhibit acute graft injury and failure in recipients harboring high numbers of pre-existing memory CD8 T cells reactive to graft alloantigens.